Modification and Pilot Testing of The Capacity cOaching And exerCise after Hospitalization for Heart Failure (COACH-HF) Intervention

Research: The current standard of care for physical rehabilitation of Veterans hospitalized for heart failure
(HF) is inadequate for 3 reasons: 1) When prescribed, Veterans may fail to engage in physical rehabilitation
due to feeling overwhelmed by their overall high treatment workload, 2) Home physical therapy is often under-
dosed and therefore fails to achieve clinical impact, and 3) Cardiac rehabilitation (CR) is rarely prescribed.
When it is utilized, its focus on moderate intensity aerobic exercise is inappropriate for severely debilitated
Veterans hospitalized for HF. I am the Principal Investigator of an NIA-funded pilot study (R03AG064371)
(BAMS-HF [Balance, Aerobic capacity, Mobility and Strength in HF] study), which provides older Veterans
recently hospitalized for HF with a novel, rigorous 1:1 physical therapist-led home-based rehabilitation
intervention that is designed to address #2 and #3 above. Although Veterans who complete the study are
enthusiastic about it, they do desire contact with other BAMS-HF Veterans and [report low motivation as a
significant barrier to participation.] These insights and challenges from the BAMS-HF study led to the current
proposal of the Capacity cOaching And exerCise after Hospitalization for Heart Failure (COACH-HF)
intervention. Based on the preliminary results of the BAMS-HF pilot study and existing literature, COACH-HF
will take a 2-pronged approach to physical rehabilitation in Veterans recently hospitalized for HF: 1) Capacity
Coaching from a Peer Support Specialist (a Veteran with HF), and 2) Physical therapist-led rigorous, in-home
strength, balance and mobility exercise protocol that will occur 3 days/week for a maximum of 12 weeks, and
monthly group exercise sessions with the physical therapist and other COACH-HF Veterans until 6 months.
[Modification of the proposed COACH-HF intervention] and pilot testing will occur over the following 2 Aims:
[Aim 1: Garner stakeholder feedback on the structure and delivery of the COACH-HF intervention using [12]
focus groups (FGs) among 3 stakeholder categories: Veterans recently hospitalized for HF, Veterans’
caregivers, and healthcare providers. Differing perspectives from the FGs will be addressed with a small
decision-making group of investigators and stakeholders. Using nominal group technique (NGT), the decision-
making group will brainstorm and rank ideas for addressing key areas of disagreement. The intervention
design will be modified by the PI based on the FG and NGT results. All FGs participants will be invited to give
feedback on the final intervention design prior to moving forward to pilot testing (i.e. member-checking).]
[Aim 2: Determine whether Capacity Coaching increases adherence to the rehabilitation intervention by
randomizing 25 Veterans ≥ 55 years recently hospitalized for HF 1:1 to Capacity Coaching + Rehabilitation
intervention (CC+Rehab) vs. Rehabilitation only (Rehab Only). Assess the feasibility and acceptability of
rehabilitation intervention (both arms) and Capacity Coaching (CC+Rehab arm).]
Candidate: I am an advanced HF trained cardiologist with an interest in physical rehabilitation for Veterans
hospitalized for HF. I am co-director of the clinical CR and HF programs at the Rocky Mountain Regional
(RMR) VAMC. My career goal is to become an independent VA rehabilitation researcher specializing in
physical rehabilitation of Veterans hospitalized for HF. This award will help me develop the skills in qualitative
research, stakeholder engagement and clinical trial design for behavioral interventions that are necessary to
achieve my career goals. The next step is to write a Merit Review application that proposes testing the efficacy
of the COACH-HF intervention.
Environment: This research will be conducted at the Rocky Mountain Regional VA Medical Center (RMR
VAMC). The RMR VAMC is a tertiary care center that is affiliated with the University of Colorado Anschutz
Medical Campus. The proposed study will leverage the existing resources and culture of supporting clinical
research within the RMR VAMC, Cariology Division and the Seattle-Denver Center of Innovation.

Public health relevance
Hospitalization for HF is the 2nd most common cause of cardiovascular hospitalization among Veterans. Patients who are hospitalized for HF often have significant deficits in strength, mobility and balance that can lead to inability to maintain functional independence. Veterans hospitalized for HF often have a high treatment workload, which leads to difficulty coping with stressors and [limits their motivation to participate in physical rehabilitation. Therefore, helping Veterans to expand their capacity to cope is important.] The COACH-HF intervention pairs Capacity Coaching with physical rehabilitation to augment Veterans’ capacity to cope with their high treatment workload - including the rehabilitation intervention. This research will [modify the proposed COACH-HF intervention] with stakeholder engagement, then evaluate feasibility, acceptability, [and improvement in rehabilitation adherence from Capacity Coaching] in a pilot study of 25 Veterans. This knowledge will be applied to a finalized COACH-HF protocol that will be tested in a larger study.